CHAIRS-C: Climate, Health, and Aging Innovation and Research Solutions for Communities

The Capacity Building Core (CBC) of CHAIRS-C will prepare Brown researchers to engage in innovative
research that reflects the complexity of climate-related public health hazards and to produce actionable
knowledge for adapting to a changing environment and reducing harmful health impacts. The CBC will foster
research projects that relate to the CHAIRS-C theme of identifying climate risks and solutions to promote
healthy aging for all, particularly those managing chronic health conditions. The long-term objective of the CBC
is to design and institutionalize transdisciplinary collaborative research and community engagement trainings
guided by the practice principles of equity and actionability and to launch multiple research projects and
scholars focused on climate impacts on the health of older adults. To achieve these long-term objectives, the
CBC will pursue the following specific aims: 1) Catalyzing new research in climate, aging, and health by
implementing a Pilot Projects Program and providing early stage and new NIH investigators with support for
research proposal development, submission, and execution; 2) Developing research capabilities in climate,
aging, and health research through a progressive sequence of activities, beginning with a Climate Change,
Aging, and Health Unconference of faculty and postdocs to identify research gaps and generate
Transdisciplinary Collaborative Teams focused on addressing those gaps, and a set of Accelerating Science
Workshops to train researchers in collaborative team science skills, community engagement, use of climate
data in health research, and modeling approaches for intervention science, among others; and 3) Expanding
capacity for research and action in climate, aging, and health by growing the Brown climate and health
curriculum at all degree levels; fostering career opportunities for undergraduate, graduate, and postdoctoral
researchers; and training older adults to prepare for and communicate climate risks. The CBC will coordinate
all capacity building activities with the Administrative Core, Research Project, and Community Engagement
Core.